Advanced Training in Community Based Research; training in Bio-informatics, Drug Resistance and Pathogenesis

ABSTRACT: Training in Climate Change and Health
Zimbabwe is a country that is climate-sensitive and studies show that the country has low
climate change adaptive capacity. The current climate patterns are expected to cause average
temperatures to rise by about 3°C and annual rainfall to decline by between 5 % and 18% in
Zimbabwe. Increases in temperature and extremes in precipitation have greatly affected the
health sector; malnutrition, diarrheal diseases, and malaria and other vector-borne diseases of
unprecedented magnitudes have been experienced in the past decade. This requires action from
the policy front and investments in multisector response strategies that work. Building
multisector capacity will initiate adaptive response that link with health system responses will
address Zimbabwe’s National and NIH/Fogarty goals. The supplement will be implemented
under the parent grant TW011326; Advanced Training in Community Based Research;
training in Bioinformatics, Drug Resistance and Pathogenesis. We propose a three pronged
approach:
To develop sustainable management of climate change and health skills: We will provide
a one health approach lens to building the capacity of health professionals for climate change
and health and to support the cascading of the learning and skills for sustainable management
of climate change and its impacts. We propose to conduct a baseline study that will inform
development of evidence based curriculum for train the trainer workshops.
To promote integration of climate change and health into curricula at tertiary education
level: We will provide a platform for the integration of climate and health into curricula of
relevant programs in colleges, universities, and hospital-based teaching programs. We propose
to use the evidence gathered at baseline to develop climate change and health curricula that
will be
To develop future research leadership: This can be achieved by supporting capacity building
of a postdoctoral fellow to conduct Climate change and health of people living with HIV
research in a mentored environment thus developing research management and grant writing
skills to sustain their careers and further climate change and health research. The fellow will
receive training that matches the parent grant postdoctoral training and support of a modest
salary and research supplies funds.
This 3 pronged approach where educational and training programs are strengthened, health
systems will become more resilient as this is one of the proactive strategies to respond to
climate change related global health emergencies such as high carbon emissions, pandemics,
biodiversity losses, air pollution and other disasters caused by shifts in climate. The training
will strengthen scientific methods to address the Public health effect of climate change on
people living with HIV. The evaluation strategies will include formative and summative
evidence of activity and output. Outcome assessment will encompass through evaluations of
trainers, students, fellow and their achievements, presentations and publications, and their
impact on curricula, policy and stakeholders.

Public health relevance
NARRATIVE This application from the BRTI responsive to Fogarty International Center (FIC) Administrative Supplements to Existing NIH Grants and Cooperative Agreements to seed new activities and partnerships in climate change and health (CCH) research and research training, Institutions will build capacity for sustainable management of climate change and health at multisector institutions in Zimbabwe. The program combines individual level and institutional level capacity building by training multisector professionals from a variety of disciplines in evidence based skills required to mitigate climate change and its effect to public health. Effective training of a postdoctoral fellow to become a research leader and champion who will develop linkages between environmental and health sectors to integrate response and develop academic and scientific leadership to guide public health policy and practice at national level.